AI-Based Image Phenotyping of Early ADPKD

Overall Project Summary: Our mission is to facilitate translational and basic research on polycystic kidney disease and related disciplines by providing access to accurate, reproducible, comprehensive measurements of all features of PKD visible on human clinical imaging (abdominal pelvic MRI and CT). This proposal builds upon a long tradition of pioneering PKD imaging research by our investigators who have been at the forefront of PKD imaging. We propose a biomedical research core that will comprehensively label images of ADPKD subjects enrolled in research or being considered for research projects. ADPKD subject image labeling will be optimized for highly accurate and reproducible Image Phenotyping by providing access to an essential “toolbox” for extracting imaging biomarkers from PKD subjects. We also provide imaging expertise tailored specifically to PKD research and access to ADPKD image data. The PKD Image Phenotyping Repository Core, will fully label and store in one secure location, all research images on PKD-RRC Core Center subjects and 400 existing subjects in our Rogosin ADPKD Data Repository, CRISP study images and more ADPKD subjects as they enroll or utilize this core. This includes annotations of 0rgans/cysts/fat/muscles for providing reports to the contributors on these critical imaging biomarkers (e.g., renal and extrarenal organ volumes, cyst volumes). This database of annotated images will empower imaging and PKD scientists to explore analytical improvements in noninvasively characterizing and measuring the anatomic features of ADPKD within all organs and tissues visible on abdominal-pelvic MRI and CT. These quantitative measurements will assess disease progression and responses to treatment within individual subjects. This proposal addresses a critical need in the PKD imaging research pipeline, from the basic science of image analysis to clinical investigation of this systemic disorder and assessing response to treatments. In addition, core leaders will pioneer solutions to the needs of PKD researchers. We expect this strategy will continue our proven track record of supporting high-impact science nationally. These activities will be organized by an Administrative Core that leverages the resources of Cornell University. Our commitment to the principle of collaborative science includes streamlining procedures for collecting and sharing images, imaging biomarkers, and expertise, integrating core activities, and collaborating with other RTCCs within the PKD Research Consortium.

Public health relevance
This pioneering work establishing an image phenotyping repository for autosomal dominant polycystic kidney disease can contribute to advancing research on cyst formation, growth, rupture as well as other effects of PKD mutations thereby advancing Public Health. Contributing to fundamental discoveries on the image phenotyping of ADPKD may help lead to useful treatments for ADPKD, methods for tracking disease progression and response to therapy as well as preventive measures positively impacting public health.